NMRbox Platform

Abstract: TRD1. The NMRbox Platform is a virtual computing environment that runs on our own infrastructure
and is available to the NMR community through a remote desktop connection or by download. We currently
host 150+ software packages for processing and analyzing NMR data. The goal of TRD1 is to enhance the
existing platform by (1) developing tools to deploy the platform, programs, and computational workflows onto
cloud computing infrastructure, (2) providing a suite of user interface tools for controlling access to software,
utilizing distributed computing resources, and managing groups of collaborators, and (3) provide platform
enhancements that engage developers and incorporate new application types into the NMRbox ecosystem,
such as HIPAA compliant workspaces. These developments empower the NMR community to tackle complex
problems in biomedicine on a freely available computing infrastructure that facilitates collaboration and
reproducible workflows. The technologies developed here also render the NMRbox computing infrastructure
transferable to other domains where a managed computing environment is desirable.